Engineering Vascularized Skeletal Muscle for Treatment of Volumetric Muscle Loss

Volumetric muscle loss (VML) is characterized by the loss of a significant portion
of skeletal muscle, leading to permanent damage to muscle structure and function.
VML results from major traumatic injury, and it is becoming increasingly more frequent
in military Veterans as a result of roadside explosions, gunshot wounds, and motor
vehicle crashes. VML contributes to long-term disability and $400 billion in economic
burden in the US annually. Traumatic injuries leading to VML are associated with
impaired endogenous muscle regeneration and revascularization capacity. Current
surgical interventions such as muscle flap grafting or scar tissue debridement are
associated with significant donor site morbidity and functional deficiency. Experimental
approaches using decellularized extracellular matrix scaffolds show limited benefit in
muscle recovery. Accordingly, a tissue engineering system that can restore normal
skeletal muscle structure and function remains lacking for treatment of VML. Since
skeletal muscle is composed generally of a bundle of parallel-aligned myofibers
interspersed with blood vessels that provide blood and oxygen to the myofibers, the
long-term goal of this proposal is to engineer vascularized skeletal muscle tissue
constructs that mimic the native muscle and vessel structure, in order to restore muscle
function after VML.
The purpose of this study is to bioengineer skeletal muscle tissue composed of
skeletal muscle precursor cells and vascular endothelial cells in a parallel-aligned
nanofibrillar scaffold that augments cell survival, myofiber formation, and vascular
perfusion recovery in a murine model of VML. Owing to the importance of vascular
perfusion recovery, the scaffolds will also be engineered to release angiogenic growth
factors in the form of modified mRNA (mmRNA), which obviates genomic alterations.
The proposed objectives are designed to advance the understanding of how
intercellular interactions with parallel-aligned nanofibrillar scaffolds, along with transient
delivery of therapeutic mmRNA, can promote muscle and vascular regeneration.
Accordingly, the Specific Aims are: (1) To engineer endothelialized aligned
skeletal muscle composed of muscle precursor cells and endothelial cells in an aligned
nanofibrillar scaffold that augments cell survival, myotube formation, and contractile
function in vitro; (2) To enhance the angiogenic capacity of endothelialized and parallel-
aligned engineered skeletal muscle using scaffold-mediated mmRNA delivery; and (3)
To quantify the therapeutic efficacy of endothelialized and aligned engineered skeletal
muscle with transient therapeutic mmRNA delivery in a murine model of VML. The
proposed studies are highly significant because they seek to improve the therapeutic
benefit of cell transplantation for treatment of VML, shifting away from the
transplantation of acellular scaffolds to pre-formed endothelialized muscle tissue
constructs with transient gene delivery for improved clinical outcomes in Veterans and
other patients with VML.

Public health relevance
Volumetric muscle loss (VML) is caused by the loss of a large portion of skeletal muscle due to traumatic injury, leading to permanent muscle damage. The incidence of VML is becoming more frequent in Veterans as a result of combat. The goal of this proposal is to bioengineer muscle that mimics normal muscle and blood vessel structure as a new strategy to treat VML. The engineered muscle utilizes nano-patterned scaffolds to organize the muscle precursor cells and endothelial cells along their normal arrangement to mimic native muscle structure. The engineered muscle will be tested in mice with VML to test its therapeutic benefit. The proposed studies are highly significant because they seek to improve the health of Veterans suffering from VML using bioengineered muscle.